Boston University Conference on Language Development, 2022-2026

PROJECT SUMMARY / ABSTRACT
We seek five years of funding to enhance diversity and accessibility at the Boston University Conference on
Language Development (BUCLD), which will take place at Boston University each year around the first
weekend in November.
Now in its 46th year, the BUCLD is internationally recognized as one of the most important annual meetings of
researchers in different areas of language acquisition and development, including first and second language
acquisition, language disorders, bilingualism, and literacy development. The meeting comprises oral
presentations and poster presentations selected through peer review, as well as invited keynote and plenary
speakers, a symposium on a topic of current interest, a NIH/NSF research funding workshop, a
professionalization workshop for students and postdocs, a pop-up mentoring program, and a sponsor exhibit.
The BUCLD serves as a prime venue for disseminating and inciting new scientific research; it brings together
researchers from all different areas of language development who do not typically interact or encounter each
other’s work regularly elsewhere, thus fostering substantial interaction across theoretical and disciplinary
boundaries. It also offers excellent training for students and postdocs, both in the form of access to high-quality
scholarship and in training activities such as the funding workshop.
In this proposal, we are requesting funds for student travel awards that will increase the quality, visibility,
interdisciplinary contribution, health relevance, and accessibility of the conference for students from
underrepresented populations, including women, racial/ethnic minorities, people with disabilities, and first-
generation college students. These student travel awards are a key piece not only for ensuring that the BUCLD
continues to be a high-quality venue for the above activities, but also for allowing the conference to grow in
important new directions that are demonstrated priorities for the scientific community as well as NIH.

Public health relevance
PROJECT SUMMARY / RELEVANCE In this conference, researchers from around the world present and discuss the latest advancements in our understanding of how humans learn first and subsequent languages, whether typically developing or with language disorders. They also share, discuss, and debate methodological advances and the implications of current research for our understanding of how the brain functions and develops, and for identification and treatment of children with language disorders.